Molecular and Cellular Mechanisms of Acoustic Startle Threshold Regulation

Project Summary. A fundamental function of the nervous system is to distinguish between threatening and non-
threatening stimuli. For example, a sudden intense sound that indicates danger should trigger an acoustic startle
response, but an innocuous sound should not. This type of behavioral threshold is a basic mechanism for
sensorimotor filtering, and the importance of setting this threshold appropriately is highlighted by the startle
hypersensitivity observed in neuropsychiatric diseases such as autism, anxiety, and schizophrenia. Despite its
importance, and in contrast to our knowledge of experience-dependent startle modulation, the molecular and
cellular pathways that establish and maintain the innate startle threshold are not well characterized. By
developing a more complete understanding of the biological mechanisms that govern the startle threshold, we
can generate new hypotheses about the neural bases for these diseases. This project will leverage the powerful
larval zebrafish model system to investigate the molecular-genetic and neural circuit bases of the startle
threshold. Here a simple, conserved, and genetically accessible circuit drives a stereotyped startle response,
with auditory afferents triggering reticulospinal neurons to activate motor neurons and initiate movement. In a
recent genome-wide screen, we identified a novel regulator of the innate startle threshold: cytoplasmic Fragile X
mental retardation protein (FMRP) interacting protein 2 (cyfip2). cyfip2 mutants are hypersensitive and startle to
low intensity sounds that rarely startle wild-types. Cyfip2 acts through FMRP and eIF4E to regulate RNA
translation, but it can also control actin polymerization through interactions with Rac1 and the WAVE regulatory
complex (WRC). In Aim 1 we will systematically test which of these molecular pathways cyfip2 uses to establish
the startle threshold and to maintain it through development. In Aim 2 we will define the cellular basis for cyfip2-
mediated threshold control by first locating the site of the primary circuit defect with optogenetic and calcium
imaging approaches and then identifying the cell types in which cyfip2 is needed for normal startle sensitivity.
Finally, our data show that acute manipulation of the actin cytoskeleton substantially alters the startle threshold
while also decreasing the number and size of excitatory synapses in inhibitory glycinergic neurons but not
excitatory glutamatergic neurons. In Aim 3 we will test the hypothesis that cyfip2 acts cell-autonomously to
maintain excitatory/inhibitory synaptic balance, combining behavioral recording with live imaging of neuronal
activity and synaptic scaffolds to define direct links between cyfip2, circuit structure and function, and behavior.
Overall, the results of this work will generate a detailed model of molecular and cellular pathways that control
the startle behavior threshold and lay a foundation for understanding how these may be affected in human
disease.

Public health relevance
Project Narrative To navigate our surroundings, the nervous system must identify which of the many stimuli we encounter are threatening enough to require a behavioral response and which can be ignored. Sensory hypersensitivity to innocuous stimuli is a hallmark of many behavioral disorders including autism, anxiety, and schizophrenia. Our research aims to determine the molecular pathways that guide the formation and function of the neural circuits that underlie this sensory filtering, with the long-term goal of establishing approaches for therapeutic intervention in disorders of sensory processing.